DFU Clinical Research Unit

Abstract
Diabetic foot ulcers (DFUs) are a prevalent diabetes complications affecting up to 25% of patients and leading
to ~80,000 Americans having non-traumatic amputations each year, with five-year mortality rates of up to 40%.
Recent evidence suggests that non-traumatic lower extremity amputations are on the rise, after decades of
decline, in spite of advances in targeted wound care products, establishment of interdisciplinary clinical and
surgical teams, and improving diabetes medical care. Given the worldwide epidemic of diabetes, the burden
associated with DFU are high, including high costs of $9 billion-$13 billion per year and besides those associated
with high morbidity and mortality. Thus, the establishment of a Diabetic Foot Consortium comprised of
experienced DFU Clinical Research Units (CRU) for reliable DFU biomarker discovery cannot be understated.
The main objective of this proposal is to integrate the robust infrastructure at Michigan Medicine with our highly
skilled clinical and translational team to establish a DFU CRU as a strong contender and contributor within the
DFC network that will be uniquely poised to participate in all DFU biomarker discovery and related wound healing
projects undertaken by the Consortium. Additional aims are to The aims are to : identify, recruit, and phenotype
a broad spectrum of DFU participants from the large base of patients with these conditions who are currently
being followed at Michigan Medicine, according to the Consortium requirements; implement standardized
mechanisms and protocols for effective longitudinal sample collection and retention; and actively participate in
the DFC intellectually and provide all available resources to develop and support clinical study protocols to
validate DFU biomarkers, including complex quantifications of wound image features; single cell, genetic,
molecular, metabolomics, and microbiome analyses; and assessing additive predictors of DFU healing beyond
clinical markers alone using multi-modal approaches.
The expected outcome of this work is that the Michigan Medicine DFU Clinical Center will be an integral part of
the Consortia collaborative network, with a highly positive impact for the entire spectrum of biomarker discovery
and future novel therapies projects.

Public health relevance
Narrative This project has major public health relevance because diabetic foot ulcers (DFUs) remain one of the most common secondary complications of diabetes and are the leading cause of lower extremity amputation in the US. Current treatments are ineffective and given the recent surge in major lower extremity amputations in diabetic patients despite the previous decades of decline, identification of novel treatment avenues is of critical importance. The main objective of the Diabetic Foot Clinical Center at the University of Michigan is to use our robust infrastructure and highly skilled clinical and translational research team to generate a unique platform for investigating individual contributions to DFU wound healing from clinical samples, single cell genetic and molecular analyses from DFU samples, and image analyses.